Optimization of Polymeric Nanoparticles Encapsulating Peptide Nucleic Acids for In Utero Gene Editing of the Fetal Brain.

PROJECT SUMMARY: Neurogenetic developmental diseases (NDD) such as Rett syndrome are severe
neurological disorders that affect thousands of newborn infants each year. As the current standard of care for
most NDDs is focused on symptom mitigation, it is imperative that a preventative intervention is developed. The
genetic mutations associated with NDDs have been shown to cause abnormal neurodevelopment from very
early stages in fetal development. In utero gene therapy (IUGT) holds the promise of a treatment that could
intervene early on in this pathologic process and prevent the development of NDDs. IUGT is advantageous
because the plasticity and developmental immaturity of the fetus offers a window of opportunity that may be
exceptionally receptive to the therapeutic agents. Previous work in gene editing has largely focused on CRISPR-
Cas9 and viral vectors, which are associated with concerns of safety including off-target effects and
immunogenicity. To address these concerns, we propose that polymeric nanoparticles (NPs) encapsulating gene
editing peptide nucleic acids (PNAs) are a superior alternative. NPs made of FDA approved polymers have
excellent safety profiles, evidenced by their approval for clinical trials, and offer extended release and targeting
through surface modifications. Because PNAs are non-nuclease based, highly stable, and bind strongly, they
offer a method of inducing site-specific gene editing with a decreased risk of off-target editing effects. PNA-NPs
have been shown to be safe agents for gene editing in multiple translational applications. We hypothesize that
in utero delivery of PNA-NPs will result in safe, highly efficient gene editing of the fetal brain.
In my first aim, I will characterize the cellular and spatial biodistribution of NPs to the fetal brain after in
utero delivery through the amniotic fluid and the vitelline vein. I will create a library of NPs made of different
polymers and different sizes loaded with fluorescent dye. After administration of these NPs in utero to time dated
pregnant mice, I will harvest fetal brains and use confocal microscopy and flow cytometry for analysis. For my
second aim, I will demonstrate the feasibility of and optimize methods for in vivo gene editing in the fetal brain
after in utero delivery of PNA-NPs. In Sub Aim 2a, I will formulate NPs encapsulating a PNA sequence developed
by our lab to introduce a beta-globin mutation. These PNA-NPs will be used to treat differentiated, post-mitotic
neuronal Lund Human Mesencephalic cells (LUHMES) and gene editing will be evaluated using droplet digital
polymerase chain reaction (ddPCR). In Sub Aim 2b, I will formulate NPs based on the optimized characteristics
identified in Aim 1. These NPs will encapsulate a PNA that allows expression of Green Fluorescent Protein
(GFP) after successful gene editing. I will administer these NPs to GFP reporter fetuses in utero and analyze the
gene editing in the brain using confocal microscopy and flow cytometry. In demonstrating the safety and efficacy
of PNA-NPs as gene editing agents targeted to the fetal brain, our project will result in an important advance in
the potential of clinically translatable IUGT.

Public health relevance
PROJECT NARRATIVE There is a pressing need for preventative treatment for neurogenetic developmental diseases, which are disorders linked to specific genetic causes that often present early in infancy or childhood with severe neurological symptoms. In utero gene therapy (IUGT) targeted to the fetal brain holds the potential to correct genetic mutations and prevent the resultant abnormal neurodevelopment at the earliest possible stage. By developing an innovative method for safe, targeted, and highly efficient neural gene editing in the fetal brain through in utero delivery of peptide nucleic acids encapsulated in polymeric nanoparticles, this project will take a groundbreaking step forward in IUGT.